Control of cell growth and size

The goal of our work is to discover fundamental mechanisms that control cell growth and size in all
eukaryotic cells. Our work is focused on two key questions:
1. How do cells measure and limit growth to control cell size? In all cells, key cell cycle transitions
occur only when sufficient growth has occurred. To enforce this critical dependency, cells must convert
growth into a proportional signal that triggers cell cycle progression when it reaches a threshold. The
mechanisms by which growth controls the cell cycle have remained deeply mysterious. We have
discovered signals that are dependent upon growth, proportional to the extent of growth, and
mechanistically linked to core cell cycle regulators, which suggests that they represent the long
mysterious mechanisms that link cell cycle progression to cell growth. Growth-dependent signaling
suggests a simple and broadly applicable solution to control of cell growth and size.
2. What are the signals that modulate cell growth and size? Observations reaching back over 60 years
point to a close relationship between control of cell growth and size. Thus, growth rate is proportional to
nutrient availability, cell size is proportional to growth rate, and growth rate is proportional to cell size.
These relationships appear to hold across all orders of life, which suggest that they reflect fundamental
principles, yet the underlying mechanisms have remained elusive. We discovered that signals arising
from a conserved TORC2 signaling network enforce proportional relationships between nutrient
availability, cell growth, and cell size. Our work suggests that TORC2-dependent signals that set growth
rate also set the threshold amount of growth required for cell cycle progression, which would provide a
simple but powerful mechanistic explanation for the proportional relationship between cell size and
growth rate.
Together, these new discoveries support transformational hypotheses that could broadly explain how cell
growth and size are controlled. Our future work will test key hypotheses arising from our discoveries, while
also carrying out mechanistic analysis to further map the remarkable signaling networks that control cell
growth and size. All of the proteins that we have identified are highly conserved. Our work therefore
leverages the experimental power of yeast to build a foundation for the discovery of mechanisms that
control cell growth and size in all eukaryotic cells.

Public health relevance
Severe defects in cell growth and size are a nearly universal feature of cancer cells and have provided the basis for cancer pathology for over 80 years, yet the underlying causes are unknown. The long-term goal of our work is to discover how control of cell growth and size works in normal cells, and how it goes wrong in cancer. With this knowledge, we hope to identify novel vulnerabilities of cancer cells that can be exploited to improve therapies.